Core A: Administrative Core

ADMINISTRATIVE CORE SUMMARY/ABSTRACT
The Administrative Core of the proposed NIA PO1 Center at the University of Pennsylvania (Penn) Perelman
School of Medicine (PSOM) is key to accomplishing the goals of all Project and other Cores. The proposed PO1
Center focuses on priorities that address Alzheimer’s Disease and related dementias (ADRD) in the topic areas
of Lewy body disorders (LBD), and multiple etiology dementias, with projects that all address the central question
of why some LBD patients develop cognitive decline early, while others develop these symptoms much later, or
not at all. We focus on mechanisms, with the goal of deriving insights that may lead to much-needed therapies
for these pathological processes. We center our program in human-derived materials, leveraging the
longstanding collection of human brain tissue and biofluids from individuals with neurodegenerative disorders at
our center.
The seven Specific Aims for the Administrative Core fall into three clusters.
Aims 1, 2, and 3 broadly support the Research Projects by (1) overseeing fiscal and budgetary matters, (2)
enhancing synergy within the PO1 Center by organizing internal meetings, including “inverted meetings,” and
(3) conducting reviews of the PO1 Center by an External Advisory Committee, which will include one individual
affected by LBD (as patient, caregiver, or other lay advocate).
Aims 4, 5, and 6 increase the impact of the Center’s activities by (4) fostering dissemination of research findings
from the Projects and Cores, (5) staying up to date on NIH policies concerning human subjects, data sharing,
resource sharing, and informing all investigators within the Center to ensure compliance, and (6) sharing human
biosamples, human biosample-derived strains, and PO1 center data with outside investigators, in collaboration
with the Resource Core and the Data Management and Statistics Core.
Aim 7 leverages the interdisciplinary nature of the PO1 center to develop translational researchers.